SCGE Disease Models Studies Supplement: Correction of RHO P23H adRP

Project Summary
The broad, long-term objective of this work is to establish a rubric to evaluate safety and
efficacy of somatic cell genome editing technologies. These goals will be addressed in
the context of an experimental therapy for retinitis pigmentosa caused by the RHO
P23H variant. The specific aims of this proposal address refinement of the therapeutic
window for this therapy, the minimum number of cells that must be edited to save vision,
and the general safety of the therapeutic strategy. These aims will be met through the
use of AAV5 to deliver an engineered meganuclease that specifically targets the
dominant P23H allele while saving the wildtype allele that differs by only one base. This
reagent will be evaluated in a validated, rapidly progressing swine model that harbors a
human RHO P23H transgene. A previously optimized dose that produces a durable
response will be delivered via subretinal injection and the animals will be followed for 32
weeks to repeatedly measure effectiveness over time via clinical eye exam, Full-Field
Electroretinogram (ffERG), and Optical Coherence Tomography (OCT). At the end of
the experiment, eyes will be examined via immunohistochemistry (IHC) to determine the
regional, minimum number of rods that must be edited to save cone function and
therefore to save vision. These experiments will be performed at two different stages in
disease progression that are hypothesized to represent the last treatable state and the
first non-treatable state so that guidance can be provided for criteria of enrollment of
patients in a future clinical trial. In parallel, animals will be similarly treated and then
sacrificed at two weeks post injection to determine the range of adjacent tissues to
which the AAV5 vector will migrate. These animals will also be used to determine the
level of editing that occurs in non-intended tissues, including the germline. All animals
will be used to obtain data on general physiological response to the therapy.

Public health relevance
Project Narrative We have developed a high fidelity, persistent, somatic cell genome editing strategy with the goal of prevention of blindness in retinitis pigmentosa patients that harbor a RHO P23H variant. These experiments will determine a state of disease progression that will represent a threshold in the therapeutic window to provide guidance for patient enrollment in future human trials. These experiments will also provide guidance on the potential for unintended edits and physiological safety concerns.